An investigation of reward brain circuitry structure and function in individuals with co-occurring alcohol use disorder and bipolar disorder and their unaffected offspring

The goal of this K23 award is to develop the applicant into an independent investigator with advanced
multimodal neuroimaging and clinical research methods skills to support his career objective of establishing a
line of research investigating reward brain circuitry as a shared etiological vulnerability to substance use
disorder and major mood disorder co-occurrence. With this award, the applicant will investigate the structure
and function of reward brain circuitry in co-occurring alcohol use disorder (AUD) and bipolar disorder
(AUD+BD) which remains largely unknown to support the development of more precise neurobiological targets
for the treatment of AUD+BD. The proposed career development and training plan is directly aligned with his
prior experience in child/family clinical psychology, social reward and decision-making, utilization of high-risk
designs, and ongoing adult AUD(+/-BD) neuroimaging research. With the support of this renowned mentorship
team, the applicant will: 1) gain advanced knowledge and proficiency in functional magnetic resonance imaging
(fMRI), diffusion kurtosis imaging (DKI), and sophisticated analyses with these data; 2) develop a deep
understanding of the neurobiology of AUD and BD from adolescence into adulthood; 3) become highly adept at
conducting family-related alcohol and BD clinical research; and 4) improve his grantsmanship for a smooth
transition to research independence. These goals will be achieved through rigorous hands-on training in fMRI
and DKI; the successful completion of neuroimaging statistics coursework with expert consultation support;
guided reading series on AUD and BD neurobiology, assessment, and treatment; intensive mentorship in
conducting neuroimaging research with families; and the successful completion of various on-campus
grantsmanship trainings. The objective of the proposed multimodal neuroimaging study is to define reward
brain circuitry structure and function among sets of parents with AUD+BD and their unaffected adolescent
offspring (dyads) against dyads defined by parental AUD alone (n=25 per group). This study is directly aligned
with two foremost NIAAA initiatives through focus on increasing understanding of AUD neurobiology in the
context of co-occurring psychopathology across age groups. The proposed aims will measure reward circuitry
brain function using social reward and decision-making fMRI tasks paired with DKI for measurement of white
matter (WM) pathway microstructure. The central hypotheses are: 1) sets of adults and their unaffected
offspring (dyads) with AUD+BD relative to AUD alone will exhibit hyperactivation to reward (with perturbed
functional connectivity) due to BD co-occurrence, and 2) WM microstructural integrity will be reduced in sets of
AUD+BD dyads relative to AUD dyads. The results of this K23 study will generate important preliminary data
for a longitudinal R01 establishing reward-related endophenotypes for AUD+BD patients who are currently
underserved by existing clinical treatments. The applicant will receive support and guidance from expert
mentors successfully conducting AUD+BD studies for the past 10+ years.

Public health relevance
PROJECT NARRATIVE Nearly 40% of individuals with bipolar disorder (BD) will develop co-occurring alcohol use disorder (AUD+BD), associated with significantly worse clinical course, poorer treatment response, and increased risk for suicide relative to AUD or BD alone. Dysfunctional reward brain circuitry is a core feature of both AUD and BD yet remains largely unexplored in AUD+BD. The proposed multimodal neuroimaging study seeks to identify neurobiological targets for improving treatment and preventative interventions for AUD+BD by defining reward brain circuitry structure and function among sets of parents with AUD+BD and their unaffected adolescent offspring (dyads) relative to dyads defined by parental AUD alone.